Training in Bioengineering Research and Technology Development in Cardiovascular in Cardiopulmonary Health and Disease

Project Summary
This proposal for pre-doctoral training on “Bioengineering Research and Technology Development in
Cardiovascular in Cardiopulmonary Health and Disease”, aims to train outstanding and diverse predoctoral
bioengineering students in applying quantitative and integrative interdisciplinary approaches to basic
and translational research in cardiopulmonary, vascular, blood and sleep pathophysiology and in
developing novel technologies for the diagnosis, treatment and clinical management of cardiovascular
and cardiopulmonary diseases. The curriculum is built on four intersecting technology themes that the
Bioengineering training faculty are expert in: (a) Biomechanics and Mechanobiology; (b) Biomaterials, Cell and
Tissue Engineering; (c) Computational and Systems Biology; and (d) Imaging and Biophotonics. Trainees will
take coursework with a concentration in two of these themes. Training faculty from the biomedical sciences will
serve as required interdisciplinary co-mentors in the major scientific areas including basic and translational
cardiopulmonary, vascular and blood research. The goal is to develop a new generation of bioengineers who
become innovators in research and technology development for improving cardiovascular health. The
leadership team has three MPIs: Dr. Andrew McCulloch (contact PI), chairs the Steering Committee (SC) and
is responsible for administration, admissions and evaluation. Dr. Karen Christman will be primarily responsible
for translational research training and Dr. Geert Schmid-Schönbein will oversee program-specific activities
including curriculum, seminars, and the annual retreat and symposium. The training faculty includes
outstanding and well-funded bioengineers, basic biomedical scientists, physician-scientists and public health
experts with exceptionally strong records of collaborative research training. The SC has established effective
recruitment, admission, training and evaluation procedures that ensure a large and diverse pool of
well-qualified candidates, 100% retention, and excellent outcomes. The curriculum will include required
program-specific courses in Cardiovascular Physiology, Molecular Biology of the Cardiovascular System,
Patient-Centered Clinical Medicine for Bioengineers, Data Science for Cardiovascular Bioengineering,
Responsible Conduct of Research and Rigor and Reproducibility, as well as bioengineering electives from two
or more of the four technology themes. With our record of successful junior faculty career development, we
include seven outstanding and diverse new junior engineering faculty recruited since 2017, including one who
has a joint clinical appointment in Cardiovascular Medicine. They will co-mentor trainees in new areas
including biophotonics, medical imaging, precision biomaterials, pulmonary arterial hypertension, heart valve
disease, and neurovascular injury. All faculty will receive mentorship training, and program progress and
outcomes will be assessed by two advisory committees and trainee surveys. The outcome will be scientists
who use integrative, technology-driven approaches to advance cardiovascular science and healthcare.

Public health relevance
Project Narrative The interdisciplinary research training provided by this program will advance the application of bioengineering technologies in improving scientific understanding of cardiovascular and cardiopulmonary diseases and developing new diagnostics, therapeutics, clinical management and prevention measures. It will train a scientific workforce that uses modern bioengineering to reduce incidence and improve outcomes in patients with heart, lung, vessel, blood and sleep disorders.